ABCB5-positive stem cells for LSCD therapy

ABSTRACT- limited to 30 lines
The corneal epithelium is a rapidly self-renewing epithelial surface essential for maintaining a clear cornea and
normal vision. The limbus contains a small subpopulation of limbal stem cells (LSCs) that continually
repopulate the corneal epithelium and patients with limbal stem cell deficiency (LSCD) are unable to
regenerate the corneal epithelium, resulting in "conjunctivalization" that ultimately leads to blindness. We
previously identified that the ABCB5 gene is expressed by LSCs in both mouse and human tissues and that
normal function of ABCB5+ LSCs is required for corneal development, homeostasis, and repair. Moreover,
ABCB5 is a cell surface protein and specific monoclonal antibodies are capable of isolating pure ABCB5+
LSCs for study and transplantation. Research from our prior grants supported the first clinical trials using
purified in vitro-expanded human allogeneic ABCB5+ LSCs for patients with bilateral LSCD (ClinicalTrials.gov:
Identifier NCT03549299). Despite our success, the use of donor allogeneic ABCB5+ LSC transplants is
suboptimal because it requires immunosuppressive treatment to prevent immune rejection of donor cells.
Allogeneic donor ABCB5+ LSCs were used because LSCD patients lack a source of healthy autologous
ABCB5+ LSCs since both eyes are involved. To solve this problem and to treat bilateral LSCD patients with
autologous ABCB5+ LSCs, this grant renewal will study three novel approaches. The first approach uses
transplantation of ABCB5+ iLSCs (induced LSCs derived from iPSCs generated from skin) using full
reprogramming of autologous skin cells, using the Yamanaka genes OSKM (Oct4, Sox2, Klf4, c-Myc) to
produce human induced pluripotent stem cells (iPSCs) that are then differentiated in vitro into 2D eye-like
organoids that remarkably contain ABCB5+ LSCs (Watanabe et al., iScience, 2021). The second approach
uses transplantation-independent restoration and expansion of residual dysfunctional or quantity-deficient
LSCs, using in vivo partial epigenetic reprogramming, a new form of reprogramming discovered by Co-PI
Dr. Bruce Ksander and collaborators (Lu et al., Nature, 2020), which uses transient expression of three
Yamanaka genes, OSK, to restore and rescue injured dysfunctional cells in vivo. The third approach uses
niche-produced LAMA5 ligand-based signaling activation of the BCAM molecular pathway that we just
discovered is critical to ABCB5+ LSC and Transient Amplifying Cell (TAC) expansion (Sasamoto et al. Cell
Reports, 2022, in press), with resultant stem cell proliferation programs that enhance corneal regeneration.
Thus, our hypothesis is that it is possible to manufacture and expand autologous ABCB5+ LSCs from patients
with bilateral LSCD using (i) full reprogramming in vitro, (ii) partial epigenetic reprogramming in vivo, and (iii)
niche-produced LAMA5 ligand-based activation of LSCs through specific BCAM/ABCB5 signal transduction
pathways. These autologous ABCB5+ LSC will fully regenerate and maintain a normal limbus and corneal
epithelium. This hypothesis will be tested in three independent specific aims that are thematically related.

Public health relevance
Project Narrative Patients with corneal injuries or disease can develop limbal stem cell deficiency (LSCD), resulting in blindness due to an irreversibly opaque cornea. While donor allogeneic ABCB5+ LSC transplants are currently already being evaluated as a therapeutic cell source for patients with bilateral LSCD, we hypothesize that it is also possible, in order to avoid immunosuppressive therapy for prevention of allograft rejection, to manufacture and expand autologous ABCB5+ LSCs for treatment of patients with bilateral LSCD using (i) full reprogramming in vitro, (ii) partial epigenetic reprogramming in vivo, and (iii) ligand-based activation of LSC signaling pathways. These autologous ABCB5+ LSC are anticipated to fully regenerate and maintain a normal limbus and corneal epithelium.